RESTEP in AZ: Regenerative Engineering, Science, and Technology Education Program in Arizona

PROJECT SUMMARY/ ABSTRACT
Healthcare spending will account for 20% of the US GDP in 2028 (>$6 trillion), and the healthcare sector
now employs 11% of the US workforce. Regenerative medicine and biomaterials will play an important role in
revolutionizing therapeutic intervention strategies to address chronic and genetic health conditions. This
challenge will require research and engineering scholars with diverse expertise, knowledge, and perspectives
to come together to identify unique solutions. However, with very few formal graduate research training
mechanisms in place, the US is falling behind in the development of young scientists who are pursuing
postgraduate degrees and employment in these important research areas in the regenerative medicine
industry. Moreover, the few opportunities that exist for graduate researchers only provide exposure to a single
dimension of stem cell biology and regenerative medicine and have limited industry-focused training and
entrepreneurship opportunities. To bridge this gap, the Regenerative Engineering, Science, and Technology
Education Program (RESTEP) in Arizona will: (i) enable trainees to build advanced experimental laboratory
research skills in regenerative medicine-focused areas while simultaneously facilitating trainees in developing
quantitative and critical skills for hypothesis formulation and testing, experimental design, and statistical data
analysis and interpretation, (ii) motivate students to develop cross-disciplinary skills, such as oral and written
scientific communication as well as responsible innovation and conduct in research, and (iii) provide trainees
with opportunities to engage and participate in multiple aspects of the stem cell biology and regenerative
medicine industry that span laboratory to market. RESTEP will recruit and support cohorts of 7 predoctoral
students each year who will be paired with faculty mentors. Over a two year period, trainees will receive
individual instruction in their thesis laboratory, learn from core technical training bootcamp short courses, and
take equipment-specific training workshops to improve their technical skills. Additionally, they will receive
guidance regarding scientific communications, responsible innovation, and responsible conduct in research.
Finally, trainees will complete entrepreneurial training, work on relationship-building with biotechnology industry
partners, and experience a formal internship. Through this training program, we seek to develop a new
generation of scientists and engineers who will drive the advancement of regenerative engineering and its
application to improve human health.

Public health relevance
PROJECT NARRATIVE This training program, led by the faculty of Arizona State University (ASU), will develop a new generation of scientists and engineers who will drive the advancement of regenerative engineering and its application to improve human health. This project is relevant to public health and NIH’s mission as it focuses on the training and workforce development of the next generation of biomedical researchers and scientists.